Preventing alcohol seeking with a nonmuscle myosin II inhibitor under clinical development

PROJECT SUMMARY
While several medications have been approved for alcohol use disorder (AUD), many patients fail to respond
or comply with the treatments. Relapse triggered by reminders of alcohol use is a particular challenge to
prevent, as the underlying memories exert a powerful motivational influence over behavior and represent a
lifelong relapse risk factor. Learning of these associations is supported by structural plasticity in dendritic
spines, driven by training-induced actin polymerization. Memory stability is subsequently achieved by arresting
actin dynamics, stabilizing the cytoskeleton. As a result, memory is impervious to actin depolymerization within
minutes of learning. However, prior work in the lab discovered that the actin cytoskeleton supporting
methamphetamine and amphetamine memories remains uniquely dynamic in the amygdala long after training.
This enables selective, retrieval-independent disruption of these memories and associated drug seeking with a
single administration of an actin depolymerizer. Because actin’s critical roles in the body limit its therapeutic
potential, focus shifted to nonmuscle myosin II (NMII), a direct driver of learning-stimulated actin polymerization
in spines. Genetic and pharmacologic targeting of NMII established it is a viable therapeutic target and an NIH-
funded medication development project for a clinically safe NMII inhibitor is underway, currently at the stage of
IND-enabling studies (UH3 NS096833). The central hypothesis in the current proposal is that a single
administration of an NMII inhibitor will produce a long-lasting disruption of alcohol seeking. Aim 1 will
determine the retrieval-independent ability of NMII inhibition to disrupt associations that trigger alcohol seeking,
like methamphetamine and amphetamine. Interestingly, the retrieval-independent effect of NMII inhibition does
not extend to memories for fear, food, spatial memory or several other drugs of abuse. However, it does
disrupt the reconsolidation of memories associated with drugs of abuse, including cocaine. Aim 2 will test the
effect of NMII inhibition on reconsolidation of alcohol-associated memories and seeking. However, the
relatively unique approach of reactivating memory with the unconditioned stimulus (US; a small amount of
alcohol), rather than the conditioned stimuli (CS; associated context and cues) will be utilized. This US-based
approach circumvents the limitation inherent to CS-based reactivation strategies, which require that potentially
hundreds of associations be recalled in a clinical setting to enable disruption. As proof-of-principle, preliminary
data indicate that US-based reactivation renders cocaine (COC)-associated memory susceptible to NMII
inhibition. The proposed work is expected to identify a new therapeutic approach to the prevention of relapse to
alcohol seeking with the potential for rapid translation through the use of a first in class compound whose NIH-
funded development is on track for FDA approval. Importantly, the proposed studies will also lay the
groundwork for an in depth mechanistic investigation in a subsequent R01.

Public health relevance
PROJECT NARRATIVE The proposed research has direct public health relevance, in that it is expected to identify a novel therapeutic approach to prevent relapse to alcohol use by targeting the motivation to seek alcohol that is triggered by long- lasting reminders of alcohol use. This will directly contribute to the mission of NIAAA with the promise of a rapid transition to the clinic, as the research will utilize a novel compound already under development for clinical use in substance use disorder.